Rheumatology & Aging Conference 2015

? DESCRIPTION (provided by applicant): The ZING conference Rheumatology and Aging will bring together scientific leaders from a number of disciplines relevant to the study of immunologic and inflammatory disorders that characterize the field of Rheumatologic, and aging and junior investigators and trainees that represent the future leaders in the field. The scientifi presentations, formal and informal discussions and poster presentations during the meeting are designed to expand our understanding of the cells that control the immune system, their function in health, disease and aging, and the role of inflammation on musculoskeletal diseases of aging. At the end of this conference the participants will understand immune cell function in health, disease, and aging. The collegial and cooperative atmosphere that characterizes a Zing Conference provides a unique setting for the intellectual development required for the implementation of novel therapies of the immune system and age related musculoskeletal diseases. The development of novel therapies based on understanding the function of the cells that control the immune system, their function in health and disease, and aging the role of inflammation on musculoskeletal diseases of aging is a goal of a number of institutes including NIAMS, NIA, and NIDCR. We propose to 1) organize state of the art talks focused on the cellular mechanisms that characterize the function of the immune system in health and disease, inflammatory states, and aging, 2) to drive collaboration and new directions of research that will enable development of treatment for disorders of the immune system and age-related disorders, and 3) facilitate interactions between trainees, junior investigators, and senior investigators and 4) encourage the involvement of women, under-represented minorities, individuals with disabilities, in immunology, rheumatology and aging research.

Public health relevance
NARRATIVE The ZING Conference “ Rheumatology and Aging” will bring together scientific leaders from a number of disciplines relevant to the study of immunologic and inflammatory disorders that characterize the field of Rheumatologic, and aging and junior investigators and trainees that represent the future leaders in the field. The scientific presentations, formal and informal discussions and poster presentations during the meeting are designed to expand our understanding of the cells that control the immune system, their function in health, disease and aging, and the role of inflammation on musculoskeletal diseases of aging. At the end of this conference the participants will understand immune cell function in health, disease, and aging. The collegial and cooperative atmosphere that characterizes a Zing Conference provides a unique setting for the intellectual development required for the implementation of novel therapies of the immune system and age related musculoskeletal diseases. The development of novel therapies based on understanding the function of the cells that control the immune system, their function in health and disease, and aging the role of inflammation on musculoskeletal diseases of aging is a goal of a number of institutes including NIAMS, NIA, and NIDCR. We propose to 1) organize state of the art talks focused on the cellular mechanisms that characterize the function of the immune system in health and disease, inflammatory states, and aging, 2) to drive collaboration and new directions of research that will enable development of treatment for disorders of the immune system and age-related disorders, and 3) facilitate interactions between trainees, junior investigators, and senior investigators and 4) encourage the involvement of women, under-represented minorities, individuals with disabilities, in immunology, rheumatology and aging research.